Extra-Corporeal Oxygenator with Minimal Blood Surface Contact

PROJECT SUMMARY
Approximately 20,317 patients globally received artificial pulmonary support via extra-corporeal membrane
oxygenation (ECMO) in 2021. During ECMO, hollow fiber membrane (HFM) gas exchangers require a surface
area of ~2 m2 to achieve therapeutic gas transfer; however, this large contact area with the blood activates the
coagulation cascade that requires systemic anticoagulation for suppression, usually with heparin. Although
heparin reduces the frequency of clotting, it does not effectively inhibit the surface deposition of platelets and
proteins. The consumption of these critical clotting components, as well as continuous administration of systemic
anticoagulant, results in an increased risk of bleeding during ECMO and increases the risk of complications and
mortality. We propose that replacing the HFM gas exchanger with a liquid perfluorocarbon blood oxygenation
system will lead to less clotting and require less anticoagulant use, reducing the incidence of both thrombosis
and hemorrhage. Liquid perfluorocarbons such as perfluorodecalin (PFD) have several characteristics to make
such a system viable: (1) They are completely immiscible with blood, allowing easy separation between the two
liquids; (2) They have ~twice the density of blood, such that blood flows up through perfluorocarbons, making a
flow system work through natural circulation; (3) They carry ~40% of their weight in oxygen and >160% of their
weight in carbon dioxide, both at STP, enabling efficient gas transfer with blood; and (4) PFD is safe in the human
body having been approved as a blood substitute in 1989. Boundless will create a device, a Perfluorocarbon
Blood Oxygenation System (PBOS) that flows oxygenated PFD into a chamber in combination with blood using
Venturi Blood Droplet generators, nozzles that create small droplets of blood with minimal shear, hemolysis, or
platelet activation. The small blood droplets gain oxygen and release carbon dioxide into the PFD quickly before
reagglomerating at the top of the PBOS. The newly oxygenated blood is returned to the body. The PFD moves
into a chamber where it is re-oxygenated and carbon dioxide is removed. This proposal seeks to identify an
optimal flow system that optimizes extracorporeal blood oxygenation (and carbon dioxide removal) while
preventing blood activation, blood damage, or adding PFD to the body. In reducing blood shear in the PBOS,
we will minimize hemolysis and blood activation. We will progress toward this objective through the following
Specific Aims: Aim 1: Optimize VDG geometry and flow rates through a combination of in-silico modeling
and prototypes. Aim 2: Quantify blood oxygenation and CO2 removal as a function of droplet sizes and
PFD flow rates. Aim 3: Demonstrate a 2 L/min system with clinically useful oxygenation, CO2 removal,
and hemolysis. Aim 4: Develop preliminary marketing and regulatory plans for the PBOS. Successful
results will not only show the potential of PBOS but will provide the necessary design guidelines to drive the
development of a clinically viable PBOS system.

Public health relevance
PROJECT NARRATIVE Extra-corporeal membrane oxygenation (ECMO) circulates a patient’s blood over a gas exchange membrane outside the body to provide artificial pulmonary support and is used when the patient’s pulmonary and/or cardiac function is severely degraded due to disease or injury. However, ECMO also causes blood coagulation that must be treated with systemic anticoagulants, which themselves cause high incidences of both clotting and bleeding. We are developing a novel “Perfluorocarbon Blood Oxygenation System” (PBOS) that replaces current ECMO components for oxygen and carbon dioxide transfer that damage blood with ones that do not; this will improve the outcomes and survival of patients requiring ECMO by increasing safely, while also potentially making the device smaller and offering the potential for ambulatory ECMO.